DP22-001 Real-world effectiveness of structured lifestyle interventions in preventing type 2 diabetes

ABSTRACT
In 2018, an estimated 88 million Americans 18 years of age and older or approximately one-third of the adult
U.S. population had prediabetes. In 2002, the Diabetes Prevention Program clinical trial demonstrated that an
intensive lifestyle intervention designed to produce and maintain a 7% reduction in initial body weight and
increase moderate physical activity to 150 minutes per week reduced the incidence of diabetes by 58% over 2.8
years. In 2010, Congress authorized the Centers for Disease Control and Prevention (CDC) to establish,
manage, and expand the National Diabetes Prevention Program (DPP). Eligibility criteria for enrollment in the
DPP (fasting glucose 100-125 mg/dl or 2-hour glucose 140-199 mg/dl or hemoglobin A1c 5.7-6.7% or high risk
score on ADA/CDC prediabetes risk screener or personal history of gestational diabetes) were broader than
those used in the clinical trial, the format of the intervention (group versus individual), the personnel delivering
the intervention (medical personnel versus trained lay leaders), the delivery mode (in-person versus virtual
(telehealth) versus online), and the duration (3 years versus 1 year) all differed from the clinical trial. Although
the trial demonstrated that the intervention was both effective and cost-effective, the long-term effectiveness and
cost-effectiveness of DPP-like programs implemented in real-world settings have not been established. The
purpose of this proposal is to assess individual and system-level barriers to and facilitators of participation in the
National DPP/Medicare DPP and to evaluate the long-term effectiveness and cost-effectiveness of the DPP as
implemented in real-world settings. By assessing individual and system level barriers to and facilitators of
participation in the DPP, and by evaluating the long-term effectiveness and cost-effectiveness of the DPP as
implemented in real-world settings, this study will provide information critical to improving the uptake and impact
of the DPP on diabetes in the United States.

Public health relevance
PROJECT NARRATIVE We propose to establish a cohort of overweight and obese adults meeting National Diabetes Prevention Program eligibility criteria who either enrolled (N=5516) or did not enroll (N=7355) in the National DPP between 2013 and 2019. We will reassess their health status 5 years after they enrolled in the DPP or entered the longitudinal cohort to: 1) identify individual and system-level barriers to and facilitators of enrollment in and completion of the DPP and 2) evaluate the long-term effectiveness and cost-effectiveness of the DPP in: a) delaying the onset of type 2 diabetes; b) improving cardiovascular disease risk factors including body mass index, hemoglobin A1c (HbA1c), blood pressure, lipid levels, and smoking status; c) reducing the incidence of cardiovascular disease including transient ischemic attack, stroke, myocardial infarction, revascularization procedures, and hospitalization for heart failure; d) improving health-related quality-of-life; and e) reducing health care service utilization and cost.